MRI Markers of Feedback Timing during Learning in Individuals with TBI with and without Clinical Depression

Project Summary/Abstract
The overall objective of the proposed project is to investigate brain mechanisms during learning in individuals
with traumatic brain injury (TBI) with and without clinical depression. Such knowledge can help guide rehabilita-
tion strategies and reduce the burden of TBI. Feedback about the accuracy of one’s actions can improve learn-
ing by informing individuals whether their action is correct or not. Individuals with depression have been shown
to have learning deficits and altered brain activity during learning compared to healthy individuals when feed-
back is presented immediately. Impaired learning through immediate feedback has also been observed in Par-
kinson’s disease (PD) patients. However, PD patients are able to learn from feedback when it is presented af-
ter a delay through engagement of separate neural mechanisms. We show that individuals with TBI exhibit def-
icits in learning through immediate feedback that are likely exacerbated by depressive symptoms. Deficits in
learning through immediate feedback can lead to perseveration of incorrect actions and decreased strategy
use during rehabilitation. However, there is no evidence directly examining the neural mechanisms of learning
in individuals with TBI with and without depression. The proposed research fills this gap. The identification of
the neural mechanisms associated with learning in individuals with TBI with and without clinical depression will
inform 1) scientific knowledge about the effect of depression on the injured brain, 2) TBI interventions about the
effectiveness of feedback and its timing, and 3) the development of generalized interventions for other clinical
populations that require rehabilitation and have high occurrence of depression. These objectives lie at the
heart of the mission of the NINDS as they will broaden “fundamental knowledge about the brain and nervous
system” associated with learning in TBI. The knowledge gained from fulfilling the above objectives will “reduce
the burden” of learning deficits after TBI. To test our hypotheses, TBI participants will be recruited based on
structured clinical interview. Qualified participants will perform an experiment where they study word pairs out-
side of the functional magnetic resonance imaging (MRI) scanner. Then, in the MRI, participants will see word
pairs in multiple-choice format, along with novel distractors, and select the correct paired-associate. After each
choice, feedback will be experimentally manipulated to be presented either immediately or after a 25-minute
delay. During the final phase outside of the MRI, participants complete a second diagnostic paired-associate
multiple-choice assessment to evaluate the influence of immediate vs. delayed feedback on learning. We hy-
pothesize that depressed individuals with TBI will show improvements in learning from delayed compared to
immediate feedback. This learning dissociation will occur because learning through delayed feedback relies on
neurocircuitry that is not negatively affected by TBI and depression. Non-depressed individuals without TBI
and clinically depressed individuals without TBI will also be recruited to differentiate the influences of depres-
sion from the impact of TBI on the brain.

Public health relevance
Project Narrative The goal of this investigation is to examine the influence of feedback timing on learning and brain activity in individuals with moderate to severe traumatic brain injury (TBI), with and without clinical depression. A paired associate verbal learning task will be used to evaluate whether differential neural circuitry, and related dysfunctional changes underlie impairments in learning from immediate in comparison with delayed feedback. We will also quantify the link between standardized neuropsychological measures and beneficial effects of learning through immediate and delayed feedback in our participants as knowing the association between standardized measures and feedback type (immediate vs. delayed) will allow clinicians to identify individuals who are more likely to benefit from a particular feedback type during learning.